Dynamics of Assembly of Bone Matrix Proteins

DESCRIPTION (provided by applicant): The extracellular matrix (ECM) has been viewed as a static three dimensional scaffold that supports cells and tissues. However, our recent molecular imaging studies in living osteoblasts have shown that the ECM is highly dynamic and that ECM molecules form structures that continually undergo movement and deformation, mediated by cell-generated mechanical forces. These studies also suggest a novel role for cell movement in ECM assembly and reorganization. Fibronectin is one of the earliest proteins to be assembled into the ECM and facilitates assembly of other matrix proteins. In the previous funding cycle, using fibronectin null cell culture models and targeted gene deletion in osteoblasts, it was shown that fibronectin is essential for assembly of multiple bone ECM components, including type I collagen, fibrillin-1, Latent TGF2 binding protein-1, decorin and biglycan and is also required for normal mineralization. Fibronectin depletion also inhibits osteoblast differentiation. Fibronectin's effects on differentiation can be rescued by supplementation with BMP2, whereas its effects on ECM assembly and mineralization cannot, suggesting that fibronectin may regulate osteoblast differentiation via ECM targeting of osteogenic growth factors. Based on these observations, the proposed studies are centered on two main hypotheses. The first is that fibronectin is a multifunctional regulator of osteoblast differentiation and function through its effects as a central orchestrator for assembly of bone ECM proteins and through its role in ECM regulation of growth factor activity. The second is that dynamic cell movement is essential for the assembly and reorganization of bone ECM proteins. To test these hypotheses, in vitro and in vivo approaches will be used in combination with live cell imaging. Aim 1 will define the cascade of assembly of bone ECM proteins and its integration with cell and matrix dynamics. This will be done using fibronectin null osteoblast models in conjunction with live cell molecular imaging of bone ECM proteins and quantification of cell and fibril dynamics by computational analysis. Aim 2 will further define the role of fibronectin in osteoblast differentiation through regulation of BMP signaling. Live cell imaging techniques will also be used with osteoblast/osteocyte lineage reporters and fluorescent probes for ECM components to determine how osteoblast differentiation and BMP signaling is dynamically integrated with ECM assembly and reorganization. Aim 3 will use novel imaging probes to determine the dynamics of collagen assembly into the ECM of osteoblasts and the role of fibronectin in collagen deposition in vitro and in vivo. The studies will provide fundamental insights, from a dynamic perspective, into the mechanisms of assembly of bone ECM and how the ECM regulates osteoblast function. The data generated will significantly advance our understanding of the molecular and dynamic mechanisms underlying bone formation and have key implications for skeletal diseases such as osteoporosis, arthritis, osteogenesis imperfecta and bone diseases related to ECM proteins.

Public health relevance
PUBLIC HEALTH RELEVANCE: This research is relevant to public health as it will provide highly novel insights into the dynamic processes by which the bone extracellular matrix (i.e. the protein scaffold outside the cells onto which mineral is deposited) is assembled. We will for the first time dynamically image the assembly process by which key bone matrix proteins are deposited in living bone cells and determine how the motile properties of the cells contribute to the building of the protein scaffold for mineral deposition. As these studies will significantly advance our mechanistic understanding the process of bone formation, the research has implications for treatment of osteoporosis, osteogenesis imperfecta and metabolic bone diseases. PROJECT NARRATIVE This research is relevant to public health as it will provide highly novel insights into the dynamic processes by which the bone extracellular matrix (i.e. the protein scaffold outside the cells onto which mineral is deposited) is assembled. We will for the first time dynamically image the assembly process by which key bone matrix proteins are deposited in living bone cells and determine how the motile properties of the cells contribute to the building of the protein scaffold for mineral deposition. As these studies will significantly advance our mechanistic understanding the process of bone formation, the research has implications for treatment of osteoporosis, osteogenesis imperfecta and metabolic bone diseases. __SpecificAimsTextDelimiter__ A) SPECIFIC AIMS The extracellular matrix (ECM) has been viewed as a static three dimensional scaffold that supports cells and tissues. However, recent time lapse imaging studies from our laboratory and others have shown that the ECM may be much more dynamic than previously thought and that ECM molecules form structures that continually undergo movement and deformation, mediated by cell-generated mechanical forces1-6. Using live cell imaging in primary osteoblast cultures, we have shown that fibronectin assembly is a highly dynamic, hierarchical process in which fibronectin is first assembled as short cell surface-associated fibrils, which coalesce to form larger fibrils7. Multiple cells contribute to the formation of individual fibrils and the fibrils continue to be physically shaped and reorganized by motile cells after they have formed. Our recent studies have confirmed that osteoblasts on the bone surface are also highly motile and have shown similar motions of fibrillar networks on the bone surface, suggesting analogous ECM assembly mechanisms in living bones. Fibronectin, a multifunctional glycoprotein, is one of the earliest ECM proteins to be assembled into the matrix and facilitates assembly of other ECM proteins8-13. In the previous funding cycle, using fibronectin null cell culture models and targeted gene deletion in osteoblasts, we have shown that fibronectin is essential for assembly of multiple bone ECM components, including type I collagen, fibrillin-1, Latent TGFβ binding protein- 1 (LTBP1), decorin and biglycan and is also required for mineralization. The absence of fibronectin appears to result in a global failure in assembly of bone ECM components. Fibronectin depletion also reduces alkaline phosphatase activity, expression of osteoblast differentiation markers and BMP signaling in osteoblasts, suggesting that it regulates osteoblast differentiation. The effects of fibronectin on differentiation can be rescued by supplementation with BMP2, but its effects on ECM assembly and mineralization cannot. Together, these data suggest that fibronectin regulates mineralization through its effects as a key orchestrator for the assembly of multiple bone ECM proteins and that it regulates osteoblast differentiation via regulation of growth factors. At present it is not known whether each of the bone ECM components whose assembly is dependent on fibronectin interacts directly with fibronectin or whether there is an assembly cascade, with some proteins interacting directly with fibronectin and others interacting with the initial binders. Further studies are needed to unravel the complex temporal and spatial relationships for assembly of bone ECM components and the integration of these processes with the differentiation of bone cells. ¿The proposed studies are centered around two main hypotheses. The first is that fibronectin is a multifunctional regulator of osteoblast differentiation and function through its effects as a central orchestrator of assembly of bone ECM proteins and through ECM regulation of growth factor activity. The second is that dynamic cell movement is essential for the assembly and reorganization of bone ECM proteins. We propose that the laying down of a fibronectin "scaffold" initiates a cascade of ECM assembly and reorganization events leading to bone formation and that fibronectin is a central regulator for the initial deposition and proper organization of bone ECM. To address these hypotheses, complimentary in vitro and in vivo approaches will be used. The specific aims are: AIM 1 - To define the cascade of assembly of bone ECM proteins, further define the role of fibronectin in the assembly cascade and determine how ECM assembly is integrated with cell and matrix dynamics AIM 2 - To determine whether fibronectin controls osteoblast differentiation through regulation of BMP signaling and determine how osteoblast differentiation and BMP signaling are dynamically integrated with ECM assembly and reorganization. Aim 3- To determine the dynamics of collagen assembly into the ECM of osteoblasts and the role of fibronectin in collagen deposition in vitro and in vivo¿. These studies will provide fundamental insights, from a dynamic perspective, into the processes by which bone ECM is assembled and how ECM regulates osteoblast differentiation. The studies have potential paradigm changing significance, as they present a novel way of viewing bone ECM as a dynamic interactive structure. The data generated will have important implications for our understanding of normal bone physiology and diseases of altered bone metabolism, such as osteoporosis.